Prevention of heterotopic ossification with localized delivery of arsenic trioxide loaded nanoparticles as a novel treatment for fibrodysplasia ossificans progressiva

Fibrodysplasia ossificans progressiva (FOP) is an ultrarare genetic disease that affects around 1
in 1.5–2.0 million live births, in which a point mutation in ACVR1, encoding the type 1 abnormal
bone morphogenetic protein (BMP) receptor ALK2, causes aberrant BMP signaling. The aberrant
signaling leads to a rapid and progressive endochondral heterotopic ossification (EHO) in skeletal
muscle and connective tissues as a hallmark of the FOP. All of FOP preventative drugs have a
systemic application and are used chronically to lessen the risk of flare-ups and/or the
development of new EHO. Therefore, there are no treatments for FOP under clinical development
that are acutely acting and/or supplied locally. Nostopharma seeks to address this need by
creating locally administered, small volume, extended-release formulations of Hedgehog pathway
(Hh) inhibitors as a promising approach to achieve a therapeutic effect, dose, and toxicity
reduction. The objective for this preclinical proof of concept is to demonstrate the feasibility of
eliminating systemic drug exposure and repurposing of clinically tested and previously authorized
inhibitors of endochondral bone formation, such as Hh signaling inhibitors, formulated in a
proprietary way, to treat a rare genetic disease-FOP. Hedgehog signaling (Hh) has a seminal role
in mesenchymal progenitor fate choice and inappropriate differentiation into osteoblasts and
ectopic bone formation in soft tissues. Although arsenic trioxide (ATO), a highly potent Hh
inhibitor, can directly block osteogenesis, chronic or systemic delivery is not an option for FOP
patients due to recognized side effects in tissues that are not the intended target. To circumvent
these restricting side effects, a proprietary formulation of ATO encapsulated in immunomodulatory
nanoparticles was developed. This proof of concept will involve screening of dose and frequency
of intramuscular administration required to significantly reduce intramuscular EHO in an
Avcr1R206H expressing mouse model of FOP.

Public health relevance
Project Narrative Fibrodysplasia ossificans progressiva (FOP), an extremely rare genetic disorder, is characterized by abnormal and progressive development of endochondral heterotopic ossification (EHO) in skeletal muscle and connective tissues. As a promising strategy to produce a therapeutic effect, dose reduction, and toxicity reduction of Hedgehog pathway (Hh) inhibitors for FOP patients, Nostopharma is creating targeted and sustained drug delivery nanoparticles. The study will evaluate the feasibility of dosing and efficacy of very potent Hh inhibitor-Arsenic trioxide encapsulated in polymeric nanoparticles towards altering the ectopic bone formation in a muscle injury mouse model of FOP.